Precision Medicine for All of Us Researchers’ Collective

Abstract
The All of Us Research Program (AoU) has created a national research dataset unprecedented in
size, diversity, and scope to advance precision medicine. However, data utilization is not yet
commensurate with the power and potential impact, and researchers utilizing the dataset are not
yet representative of communities historically underrepresented in biomedical research (UBR).
The AoU's innovative cloud-based, centralized data governance requires broad professional
development training for researchers, with a focus on informatics literacy and technical resources
to support analysis within the AoU Researcher Workbench (AoURW). The University of Arizona
(UArizona)-Banner AoU team will address this challenge through four Aims derived from our
extensive experience leading interdisciplinary scientific teams to utilize AoURW and creating
programs to engage researchers from UBR communities. Aim 1: Establish an AoU Data Fellows
program to train and mentor researchers from UBR communities in leveraging the AoURW. Data
Fellows will subsequently engage in outreach within their own networks to encourage AoUfocused research projects and awareness. Aim 2: Advance and manage a biomedical informatics
core dedicated to equipping UBR and nontraditional researchers to conduct research in the
AoURW. Aim 3: Incentivize AoURW research through high priority driver projects and seed
grants with a focus on UBR and early-career investigators and health equity research. Aim 4: Form
an Advisory Council (AC) to oversee Aims 1-3 and create partnerships with scientific
organizations to engage researchers and scale initiatives nationally. Aims 1-4 will cultivate an
active, diverse, and sustainable pool of AoU-focused researchers empowered by our resources and
AoURW’s directive to advance precision medicine for the benefit of all communities. We will
engage researchers from UBR communities to utilize the AoURW using active engagement
strategies based on the principles of community based participatory research and research capacity
building, while maintaining the flexibility to work with existing AoU partners and extend AoU
resources. Our UArizona-Banner AoU team will assess the impact of our activities, disseminate
promising practices to the broader scientific community, evaluate our initiatives against AoU
programmatic objectives, and ensure that our researchers’ perspectives inform AoURW
development—driving AoU further toward an inclusive ecosystem and an equitable platform.

Public health relevance
The All of Us Research Program has created a national research dataset that is unprecedented in size and scope to advance precision medicine. This project aims to enable researchers to effectively and rigorously utilize All of Us data for scientific discovery. The proposed research is relevant to public health because it has the potential to accelerate biomedical research, generate new knowledge, and reduce the public health burden of a wide variety of diseases. Thus, the proposed projects are relevant to the part of the NIH mission that pertains to a focus on improving population health and supporting rigorous, reproducible, and unbiased research.